Defining cellular and molecular processes underlying adipose tissue dysfunction onINSTI-based antiretroviral therapy

PROJECT SUMMARY/ABSTRACT
The introduction of the integrase strand transfer inhibitor (INSTI) class of HIV drugs transformed the treatment
of persons with HIV (PWH), offering highly effective and well-tolerated options with fewer drug interactions.
However, concerns about INSTIs causing weight gain, particularly in women, have been raised in various studies.
Despite recent investigations, a definitive explanation for the mechanism behind INSTI-associated weight gain
remains elusive. Recently, we reported that the administration of dolutegravir led to an increase in fat mass and
body weight through suppression of thermogenic processes in a rodent model, which was associated with a
disruption of mitochondrial respiration and reduced expression of uncoupling protein1 (UCP1) in adipose tissues.
Moreover, other groups further confirmed these results using non-human primates (NHPs) infected with SIV.
Interestingly, it has been well-documented that estrogen plays a critical role in promoting thermogenic processes
through the peripheral and central nervous systems. Our preliminary data shows that dolutegravir inhibits
estrogen signaling action, and genetic deletion of estrogen receptors in adipocytes attenuates dolutegravir-
mediated suppression of the thermogenic process. Based on these observations, we hypothesize that
dolutegravir reduces energy expenditure via disrupting estrogen action in adipocytes, leading to the weight gain
associated with INSTIs. To further investigate this hypothesis, we will first define the molecular mechanisms by
which INSTI-based ART disrupts whole-body metabolism and leads to weight gain via the estrogen receptor (ER)
using a transgenic mouse model in which ER is genetically deleted in adipose tissues. We will perform
biochemical and molecular analyses combined with multi-omics approaches, including single-cell RNA and
ATAC-sequencing to further elucidate the molecular network associated with INSTI-related adipose function
disruption via ER (Aim 1). Next, to address the absence of a chronic retroviral infection in a murine model, we
will investigate how estrogen affects INSTI-based ART-mediated weight gain over time via disrupted
thermogenesis in NHPs infected with SIV and ovariectomized with or without estrogen replacement. We will also
perform temporal transcriptomic analyses on adipose tissues to gain a comprehensive understanding of how
these tissues are altered through infection, ART initiation, and E2 manipulation over time (Aim 2). Finally, we will
evaluate the effects of INSTI-based ART on thermogenic pathways and mitochondria functions in adipose tissue
at multiple time points from PWH starting INSTI-based treatment and followed for one year. Moreover, we will
perform integrative transcriptomics analyses utilizing cross-species omics data (Aim 3). These multidisciplinary
and translational works will shed light on how INSTIs contribute to weight gain, especially in females, and inform
the development of new strategies to reduce excess adiposity and metabolic dysfunction in PWH.

Public health relevance
NARRATIVE The introduction of the integrase strand transfer inhibitor (INSTI) class revolutionized the treatment of people with HIV infection due to their high efficacy, greater tolerability, and fewer drug-drug interactions. However, recent studies have raised potential concerns for weight gain in patients receiving INSTIs, especially in women. This proposal will elucidate a potential sex-dependent mechanism by which INSTIs disrupt metabolic balance, leading to weight gain.